Insights into the origin of ACPAs in RA

PROJECT SUMMARY/ABSTRACT
Citrullination is a physiologic post-translational modification found across multiple normal human tissues. Why
this modification is the most important target of antibodies in rheumatoid arthritis (RA) is unknown. While the
pathogenic role of anti-citrullinated protein antibodies (ACPAs) remains uncertain, the striking association
between ACPAs and RA has raised the possibility that understanding the origin of these antibodies may shed
light on the cause of RA. Interestingly, our preliminary studies provide evidence that ACPAs may originate from
a distinct antibody targeting a different but structurally similar modification, known as carbamylation. Our
overarching hypothesis is that ACPAs can arise during affinity maturation of germline encoded antibodies to
carbamylated proteins. In this proposal, we will use RA-derived monoclonal ACPAs to support or discard this
novel hypothesis. If the proposal is successful, this work may uncover a mechanism for why citrullinated proteins
become immunogenic and potentially to support germline encoded antibodies to carbamylated proteins as initial
players in the development of RA.

Public health relevance
Narrative The production of antibodies to modified proteins is a hallmark in rheumatoid arthritis (RA), but their origin is unknown. The proposed studies will investigate a novel mechanism to explain the origin and mechanistic relationship of antibodies to citrullinated and carbamylated proteins in RA.